KINASES &EARLY RESPONSE GENES IN OROFACIAL DEVELOPMENT

The extensive alterations in tissue morphology, cellular biochemistry and regulation of gene expression that culminate in the genesis of the midface result from the interaction of multiple hormone- and growth factor-activated signaling pathways. Little attention has been focused on characterization of these pathways and the nuclear events responsible for transducing short-term cellular signals into long-term phenotypic alterations associated with normal orofacial development. This application investigates 1) the role of the signal transducer protein kinase C in mediating the effects of various palatal hormones and growth factors and 2) the role of 'early response' nuclear oncogene families in protein kinase-mediated signal transduction during growth and differentiation of the mammalian secondary palate.